High-speed imaging of cortical and white matter microvascular flow in AD/ADRD models

Summary: High-speed imaging of cortical and white matter microvascular flow in AD/ADRD models
Although vascular risk factors and cerebrovascular dysfunction are known to be pathogenically linked to
AD/ADRD, the mechanisms are not well understood. In AD/ADRD mouse models, several causes of decreased
blood flow and regulatory dysfunction that operate at different levels of the microvascular network have been
identified. In mice overexpressing mutant genes that cause AD and in mice with genetic and cardiovascular risk
factors for neurodegeneration, decreases in cerebral blood flow, impairment of neurovascular coupling,
narrowing of capillary lumens by pericytes, and stalling of capillary flow by arrested white blood cells have been
reported. However, much remains unknown because current approaches for quantifying microvascular flow are
insensitive to events occurring in individual microvessels in a network (i.e. they measure averaged flow across
many vessels so miss an event like a capillary stall) or are unable to evaluate network flow and perfusion changes
caused by microvascular events (i.e. they measure too few vessels at a time to quantify up- and down-stream
flow or regional perfusion changes due to a capillary stall). Flow and perfusion decreases and heterogeneity
arising from such events could play an important role in the progression of neurodegenerative disease, as
network microdomains with persistent or repeated epochs of network hypoperfusion – “oligemic micropockets”
– may be hotspots for brain cell dysfunction, amyloid accumulation, and microinfarcts. Measurement of flow
speed in every microvessel across a connected network is needed to investigate how transient microvascular
events impact network blood flow and tissue perfusion. This proposal seeks to develop and test a paradigm-
shifting approach to 2- and 3-photon (2P and 3P) excited fluorescence imaging to achieve the speed and depth
penetration necessary to simultaneously measure flow in ~300 microvessels in the neocortex or ~50 in the deep
subcortical white matter (WM) of mice. An adaptive excitation source (AES) generating femtosecond laser pulses
“on demand” is synchronized with fast 3D raster scanning and is programmed to fire pulses only where blood
vessels reside. Because the maximum laser power that can be delivered to the brain is rate limiting, AES restricts
2P/3P excitation pulses only to blood vessels enabling measurement of the speed, diameter, and signals from
additional cell type-specific fluorescent labels from all microvessels in a 300x300x300 µm3 volume in the cortex
or in a 200x200x100 µm3 volume in the deep WM (100 Hz volume imaging with 1x1x10 µm3 voxel size) (Aim 1).
This innovative imaging capability will be used to explore the collective impact and causal links between selected
molecular and cellular mechanisms of CBF abnormality in the cortex of AD mouse models, as well as to test the
hypothesis that oligemic micropockets are sites of amyloid deposition (Aim 2). The ability of AES imaging to
explore network flow and perfusion in the deep WM of mice enables the examination of the impact of genetic
and cardiovascular risk factors associated with AD/ADRD on the WM microvascular network to provide novel
insights into how global hypoperfusion induces WM damage at the microscale level (Aim 3).

Public health relevance
Narrative Understanding how slowed and dysregulated blood flow in the brain increases the risk for and severity of Alzheimer’s disease and related dementias has been impeded by a lack of approaches for measuring flow speed and regulation across connected networks of small blood vessels. The new adaptive excitation source two and three photon excited fluorescence imaging developed here will measure blood flow in hundreds of microvessels at once, and will be used to explore causes and consequences of blood flow abnormalities in mouse models of Alzheimer’s and white matter disease.